Cellular signaling mechanisms that drive persistent hyperexcitability in nociceptors

Project Summary
Chronic pain is notoriously insensitive to treatment with opioids. This research project aims to uncover
signaling mechanisms in sensory neurons that are important for persistent pain and opioid resistance. In
addition, the project aims to test new potential treatment options for ongoing pain using rat models of
spinal cord injury (SCI) and surgical injury. Ongoing or spontaneous activity in primary nociceptors
contributes to the maintenance of many forms of chronic and persistent pain, including pain after SCI or
surgical injury. This project extends findings that i) chronic nociceptor hyperexcitability after SCI requires
signaling through multiple cAMP effectors and crosstalk with the Ras/MAPK pathway, ii) SCI reduces AC
inhibition by Gαi/o and thus the potency of opioids (DAMGO, morphine) on dorsal root ganglion (DRG)
neurons, and iii) unexpectedly, gabapentinoid drugs (gabapentin and pregabalin) that often are used for
treatment of neuropathic pain reverse both SCI-induced DRG neuron hyperexcitability and opioid
resistance due to inhibition of L-type voltage-gated calcium channels (VGCC). This project explores the
novel prediction that FDA-approved L-VGCC inhibitors can enhance opioid treatment of severe pain.
Recent findings also suggest potential roles for L-VGCC inhibitors in treating surgical pain, which unlike
SCI, can resolve but reappear after an injury heals. Preliminary findings indicate that nociceptor
hyperexcitability, like pain sensitization, remains latent for long periods after remission of postsurgical pain
because of continuing activation of opioid receptors. Three related hypotheses will be tested: 1) sustained
membrane depolarization occurring after SCI decreases opioid sensitivity via opening of L-VGCC to
activate C-Raf, with downstream ERK activation combined with cAMP signaling driving nociceptor
hyperactivity and consequent chronic pain; 2) the same signaling loops promote opioid resistance in
human DRG neurons, and 3) after surgical injury—representing conditions where pain resolves while a
latent sensitization persists—these mutually reinforcing mechanisms are readily retriggered to reinstate
nociceptor hyperactivity and enhanced pain. These hypotheses will be addressed with biochemical, high
content imaging, whole-cell patch electrophysiology, and sophisticated behavioral methods in three
specific aims. Aim 1) Determine contributions of L-type voltage-gated calcium channel signaling to human
and rat opioid resistance, nociceptor hyperactivity, and rat pain behavior. Aim 2) Define molecular
mechanisms that drive opioid resistance and hyperexcitability of nociceptors. Aim 3). Define signaling
mechanisms regulating nociceptor hyperexcitability and associated pain after surgical injury. Importantly,
our model identifies multiple drugs that have been FDA-approved for other applications but offer promise
for both enhancing endogenous opioid responses and reducing the nociceptor hyperactivity that drives
ongoing pain and central sensitization after many forms of severe injury.

Public health relevance
Project Narrative: This joint project will define mechanisms in injury-detecting sensory neurons that contribute to life-long chronic pain after spinal cord and surgical injury. It follows up on discoveries that spinal cord injury causes a large number of these sensory neurons to change from their normal state of electrical silence into a persistent state of spontaneous activity with reduced responsiveness to opioids. We now test novel targets for reversing the spontaneous activity and resistance to opioids for treating reappearing surgical pain and chronic pain after spinal cord injury.